Cellular Source-Dependent Effects of ApoE4 on Tau Pathology in Alzheimer's Disease

PROJECT SUMMARY
Alzheimer's disease (AD) is a progressive neurodegenerative disorder that is the sixth leading cause of mortality
in the United States and costs $305 billion annually. The strongest genetic risk factor for AD is the ε4 variant of
the APOE gene (APOE4), which is found in 60-75% of all AD patients. Despite the importance of apoE4 in AD,
the exact role of apoE4 in the pathogenesis of AD remains poorly understood. The proposed studies will fill
critical gaps in knowledge by dissecting how different cellular sources of apoE4 modulate tau pathology,
neuroinflammation, and neurodegeneration in Alzheimer's disease.
It was recently discovered that apoE4 causes increased tau pathology and neurodegeneration. While the
detrimental effects of apoE4 on neuronal survival and cognition depend on whether it is produced in neurons or
astrocytes, it is unknow if neuronal and astrocytic apoE4 differentially modulate tau pathology and
neurodegeneration, which are two critical hallmarks of AD. Additionally, it is unclear if apoE4 can directly induce
tau pathology or if the effects of apoE4 on tau are primarily driven by the effects of apoE4 on other pathologies.
The proposed studies in this application will determine if apoE4 can directly induce tau pathology and if the
effects of apoE4 on tau pathology and neurodegeneration are dependent on the cellular origin of its production.
ApoE4 may also play an important role in the activation of neuroinflammatory cells since it leads to increased
microgliosis and astrogliosis. Depletion of microglia was also found to reduce the extent of tau pathology and
neurodegeneration. Still, it is unknown if removal of neuronal or astrocytic apoE4 will have protective effects on
activation of neuroinflammatory cells and on neuroinflammatory cell-mediated and neurodegeneration.
In summary, the proposed studies will test the central hypothesis that neuronal and astrocytic apoE4 expression
differentially drive tau pathology, activation of neuroinflammatory cells, and subsequent neurodegeneration. The
central hypothesis will be investigated using mice that co-express P301S mutant tau and LoxP-floxed human
apoE isoforms, in which the human APOE gene can be deleted in astrocytes by expression of GFAP-Cre or in
neurons by expression of Syn1-Cre. I will accomplish two aims: (1) Determine if the detrimental effects of apoE4
on tau pathology and neurodegeneration are dependent on its cellular source, and (2) Elucidate the role of
different cellular sources of apoE4 on neuroinflammation and neuroinflammatory cell-mediated
neurodegeneration. The proposed research will elucidate the fundamental mechanisms of apoE4-related AD
pathogenesis and will potentially identify novel targets for future AD therapies.

Public health relevance
PROJECT NARRATIVE This research proposal aims to determine if neuronal and astrocytic apoE4 differentially modulate tau pathology, neuroinflammation, and neurodegeneration in Alzheimer's disease (AD). The proposed studies will also examine if apoE4 directly induces tau pathology or if its effects on tau are primarily driven by its effects on other pathologies. The outcome of the proposed studies will provide critical insights into the pathogenesis of Alzheimer's disease and will potentially reveal new therapeutic targets for AD drug development.